Molecular mechanisms of compound microtubule structure and function

PROJECT SUMMARY
The mammalian centrosome-cilium complex is involved in cell division, signaling, and motility. Defects in the
structure or function of the complex are linked to a variety of human disease states, including cancer,
microcephaly, and a group of inherited disorders known as ciliopathies that affect many tissues and organs.
The centrosome is composed of two centrioles surrounded by pericentriolar material and is the major
microtubule organizing center of animal cells. One of the centrioles within the centrosome templates the growth
of a cilium, an antenna-like organelle involved in cell signaling and motility.
While the field has catalogued many of the hundreds of proteins in the complex, how they work together to
create functional centrosomes and cilia is unclear. We propose that specialized, compound (triplet and
doublet) microtubules within the complex form dedicated scaffolds for the protein-protein interactions
that define the organelle. Triplet microtubules in centrioles and doublet microtubules in cilia are conserved in
almost all species with these organelles and are only found in centrioles and cilia. Little is known about how
these microtubules are formed and regulated to create functional organelles. Delta-tubulin and epsilon-tubulin,
two little-studied members of the tubulin superfamily, are key proteins involved in forming compound
microtubules at the centrosome-cilium complex. Null mutations in either delta- or epsilon-tubulin in mammalian
cells results in the formation of aberrant, unstable centrioles with singlet microtubules that fail to recruit many
centrosome proteins. The molecular mechanisms by which these tubulins act on centrioles are unknown. Here,
using a combination of high-resolution expansion microscopy, CRISPR/Cas9 gene editing, biochemistry, and
proteomics, we will address outstanding questions about the structure, formation, and function of the
compound microtubules. We will: 1) determine the molecular mechanisms by which delta-tubulin and epsilon-
tubulin form or stabilize the compound microtubules, 2) define how the compound microtubules elongate, and
3) determine how the compound microtubules scaffold the centrosome-cilium complex. These studies will
provide mechanistic insight into the assembly of these microtubule structures, improve our understanding of
the centrosome-cilium complex, and provide insight into its dysregulation in disease.

Public health relevance
PROJECT NARRATIVE The centrosome-cilium complex is present in almost all cell types of the human body and is involved in cell division, signaling, and motility. Defects in the structure or function of the complex are linked to a variety of human diseases, including cancer, microcephaly, and ciliopathies. Our research will identify the mechanisms by which the centrosome-cilium complex is built and regulated, contributing to our knowledge about disease progression and potentially leading to the development of new therapies.